Natural products inhibitors targeting homology-directed DNA repair for cancer therapy

ABSTRACT
Genomic instability is a hallmark of cancer. Genome destabilizing defects in DNA repair enable tumorigenesis
and cancer progression pushing cancer cells into dependence on a specific subset of DNA repair and genome
maintenance factors. Two such targets of the proposed program are DNA repair proteins RAD51 and RAD52.
The flexibility and adaptability of DNA repair networks allows cancer cells to employ them to enable rapid
evolution, progressive accumulation of genetic variation, genomic instability, the acquisition of invasiveness,
drug and radiation resistance and disease progression. Cells deficient in homologous recombination (due, for
example to defects in tumor suppressors BRCA1 and BRCA2) require RAD52 for survival, while overexpression
of RAD51 in cancers promotes radiation and chemotherapy resistance. Both proteins rely on their ssDNA binding
to carry out their cellular functions. Inhibition of DNA repair by interfering with RAD52 or RAD51 binding, or
entrapment of the toxic DNA repair intermediates with the help of small molecules has significant therapeutic
potential. Identifying disruptors of ssDNA binding specific to each protein represents a tough medicinal chemistry
challenge, but is a prerequisite for tailored low toxicity therapies. Natural products have an unrivaled place in
early stage drug discovery and occupy an unparalleled chemical space for protein binding, which will be
employed to elucidate the structural and chemical aspects of specific inhibition of our target proteins.
Our published and preliminary studies established robust biophysical (FRET-based) assays to monitor the
ssDNA binding by RAD51, RAD52 and Replication Protein A (RPA), a major human ssDNA binding protein
whose inhibition is likely to be toxic. Proof-of-principle screens confirmed that we can readily identify small
molecules and natural products specifically inhibiting each of the three proteins. We have also developed a
computational workflow that accurately predicts interactions between small molecules and the DNA binding
groove of RAD52. Here, we propose to carry out a screening campaign to identify a range of natural product
scaffolds that can be developed into potent, specific and non-toxic disruptors of the RAD52-ssDNA interaction
and to build a framework for discovery of RAD51 natural products inhibitors. We will screen a unique library of
natural products, an NCI Program for Natural Product Discovery (NPNPD) Prefractionated Library consisting of
320,000 fractions, which were produced by separating the unique crude extracts derived from plant, marine, and
microbial organisms. Our high throughput screening and compound validation (Aim1) followed by in silico
analysis (Aim2) will yield sets of natural products scaffolds that will inform us on the regions and structural
features within the target site of RAD52, that can be targeted to achieve specificity and high affinity, and on the
chemical signature of the potential specific hits. Structure-activity relationships and rules for specificity learned
from these campaigns can be then utilized in scaffold hopping approaches to new synthetic RAD52 inhibitors.

Public health relevance
PROJECT NARRATIVE Often cancer cells are “addicted” to specific DNA repair pathways to support rapid cell proliferation and resistance to radiation and DNA-damaging chemotherapeutics. DNA repair mechanisms, which cancer cells depend on to a much greater extent than normal cells, offer targeting opportunities for discovery of new effective therapeutic agents. The vast chemical space afforded by natural products will allow us to generate leads that will be employed to develop specific and non-toxic inhibitors of key DNA repair proteins RAD52 and RAD51 whose activities many cancers depend on.